An assessment of environmental and neighborhood-level risk factors for subfertility among Black women in the U.S.

Project summary
This application for the Research Supplement to Promote Diversity in Health-Related Research (PA-23-189)
proposes a research and career development plan to develop the independence of Dr. Brittney Francis
through a study titled, “An exploration of segregation, neighborhood-level contextual factors and maternal
hypertension among Black women in the U.S. using causal inference methods” for the award period of
07/01/24-06/30/26 to enhance the parent grant, “An assessment of environmental and neighborhood-level risk
factors for subfertility among Black women in the U.S.” (R01-ES035053; PI- Dr. Amelia Wesselink). The
proposed supplement study will conduct a secondary analysis using causal mediation methods with the
overarching goal of examining the complex association between racial residential segregation, neighborhood
level contextual factors, and hypertensive disorders of pregnancy (HDP) in the Black Women’s Health Study
(BWHS). HDP is an important public health problem for many reasons. A person impacted by an HDP is more
likely to experience other maternal complications and adverse sequalae associated with them which has
immediate and long-term health impacts across an individual’s lifecourse and their offspring. This study will use
existing (through parent grant) and new data linkages to the BWHS to specifically examine food access and
exposure to environmental toxins as mediators between the relationship of racial and economic segregation
and HDPs among Black women. This proposed diversity supplement will significantly contribute to furthering
our understanding of the role of structural racism in shaping risk of maternal HDP and points of intervention
that can decrease the health inequities we see for Black women on a population level. This proposed research
is critical, timely and can be translated to impact current policy decisions about neighborhood infrastructure
and development that will advance reproductive health equity, promote reproductive justice, create safe and
healthy neighborhoods, and reduce the costs due to health disparities in this country.

Public health relevance
Project narrative Inequities in the built environmental factors have been linked to inequities in our social environment, particularly for low income racially marginalized communities. This project will examine the direct effects of racial and economic segregation and the indirect effects of potential mediating neighborhood level built environmental factors on hypertensive disorders of pregnancy among Black women in the U.S. We hope this will increase our understanding of the interplay between the social and built environment to better inform population health interventions and outcomes related to maternal morbidity and mortality.